Maternal and Paternal Behavior Associated with Parent-Child Brain Synchrony

Project Summary
Parental sensitivity, or the ability to accurately perceive and respond to children's signals1, is crucial for
supporting the development of self-regulation in offspring2,3. The significance of maternal sensitivity in
adaptive child development is well-known1,4–6, but fathers are understudied despite increasing involvement in
caregiving7–10. Consequently, measures of parental sensitivity are often generalized from maternal research to
paternal behavior, increasing the potential for bias and overlooking the nuance of paternal caregiving.
According to the extended parent-child emotion regulation dynamics model11,12 and synchrony model3, brain
and behavioral processes that are synchronous, or coordinated, between parents and children during
interactions index more effective co-regulation and parent-child relationship quality13,14,15. Critically, both
effects specific to and independent from caregivers' biological sex have been observed in relation to sensitive
parent behaviors16–23, which likely contribute to parent-child biological synchrony. For example, biological
females typically exhibit both verbal and nonverbal engagement with offspring while biological males exhibit
more nonverbal engagement16–19, and both forms of sensitivity have been shown to support healthy
development in offspring24–26. However, such effects are rarely analyzed in the context of single study across
multiple levels of analysis. To provide a basic science foundation for a more holistic understanding of mothers
and fathers as effective caregivers, I will test biological and behavioral mechanisms underlying parent-child
interactions in mothers and fathers. I will use measures of verbal and nonverbal mentalizing, or the ability to
understand children's mental states which underlies overt caregiving behavior, as an index of caregiver
sensitivity24,25,27. I will also use measures of parent-child brain synchrony as an objective index of co-regulatory
quality during interaction13. Using a publicly available dataset of concurrent Functional Near-Infrared
Spectroscopy (fNIRS) recordings from parent-child dyads (N=62; mother-child n=33, father-child n=29, child
ages 34-60 months) during free play interaction, I will test whether the relation between parent mentalizing
(verbal, nonverbal) and parent-child brain synchrony depends on maternal or paternal status in order to
understand whether caregiving sensitivity manifests and/or differentially impacts parent-child interactions
between biological male and female parents. To understand the development of differing but effective
caregiving behaviors between biological male and female caregivers, I will also test parents' own caregiving
histories as a predictor of mentalizing capacities (verbal, nonverbal) and parent-child brain synchrony. Overall,
this work will provide further evidence for both sex-independent and sex-dependent caregiver behavioral
effects on dyadic relations, highlighting the strengths of complementary but equally effective caregiving roles.
Further, this work has the potential to inform future assessment and intervention supporting sensitive parent-
child interactions among diverse caregivers, strengthening the overall family system.

Public health relevance
Project Narrative Relative to mothers, fathers remain understudied as caregivers; as a result, measures and conclusions regarding parental sensitivity are often generalized from maternal research to paternal behavior, increasing the potential for bias and overlooking the nuance of paternal caregiving. To provide a basic science foundation for a more holistic understanding of mothers and fathers as effective caregivers, I will test parents' real-time mentalizing behaviors (verbal, non-verbal) and historical caregiving experiences as predictors of parent-child brain synchrony, indexing co-regulatory quality. By identifying shared and/or unique behavioral mechanisms contributing to sensitive caregiving interactions observable on the neural level between parents and children, my work can indirectly inform policies for effectively engaging with and supporting mothers and fathers, strengthening the overall family system.